A brief alcohol intervention to reduce alcohol use and improve PrEP outcomes: A randomized controlled trial.

Unhealthy alcohol use is common among people using pre-exposure prophylaxis (PrEP). Unhealthy alcohol use is a spectrum from risky/hazardous drinking to alcohol use disorder. For people on PrEP, unhealthy alcohol use may reduce PrEP persistence and adherence, which are critical for HIV prevention. Reducing unhealthy alcohol use may improve PrEP outcomes. The brief alcohol intervention (BAI), which draws on Motivational Interviewing and Cognitive Behavioral Therapy, increases viral suppression among people living with HIV on antiretroviral therapy. This effect is mediated through increased adherence. The BAI may have a similar effect on PrEP outcomes among people with unhealthy alcohol use. We propose an effectiveness-implementation type 1 hybrid randomized controlled trial (RCT) to compare the BAI to standard of care among people with unhealthy alcohol use initiating or re-initiating PrEP in Vietnam. We hypothesize that the BAI will improve a) PrEP persistence, b) PrEP adherence, and c) risk-aligned PrEP use (PrEP use consistent with current risk, including event-driven PrEP). Our specific aims are to: 1) Assess effectiveness of the BAI for increasing PrEP persistence and adherence among people in Vietnam; 2) Assess the impact of the BAI on alcohol use among people using PrEP; 3) Estimate the cost-effectiveness, feasibility, and acceptability of scaling up the BAI in PrEP clinics throughout Vietnam. The trial and intervention will be conducted at the Hanoi Medical University PrEP clinic in Vietnam. Evaluation visits will be conducted at UNC Project-Vietnam. Eligible participants will include people (n=564) 16 years of age or older presenting to the PrEP clinic for PrEP initiation or re-initiation after at least 3 months from a missed PrEP appointment, based on local PrEP guidelines. The participants must also screen positive for unhealthy alcohol use with an AUDIT-C score ≥ 4 or have a CRAFFT score ≥ 2 (for those ≤21 years old). After baseline evaluations, participants will be randomized to either standard of care or the BAI, which comprises two in-person and two telephone visits. Each participant will be followed quarterly with interviews, including use of timeline followback to elicit alcohol use, and tests for HIV infection. Alcohol use and PrEP adherence will also be assessed with biomarkers. The primary effectiveness outcomes are PrEP persistence and heavy drinking days. Secondary outcomes include PrEP adherence, assessed by self-report, pharmacy records, and validated bioassays; risk-aligned PrEP use; and alcohol outcomes (number of drinking days; and drinks per drinking day). The primary implementation outcomes are the incremental cost-effectiveness ratio, expressed as the incremental cost per quality-adjusted life-year gained, and feasibility and acceptability. If successful, this study will be set to ensure rapid scale up of an intervention to improve lives by reducing unhealthy alcohol use and increasing PrEP use for HIV prevention.

Public health relevance
This study will be the first to assess the effectiveness and cost-effectiveness of the brief alcohol intervention (BAI) among people with unhealthy alcohol use who initiate or re-initiate PrEP. By simultaneously addressing two important public health issues for people initiating or re-initiating PrEP (PrEP persistence and unhealthy alcohol use), we will determine whether the BAI improves these outcomes among PrEP initiators and re-initiators in an Asian setting, where alcohol use is widely accepted socially. In using a hybrid, type I design, we facilitate rapid expansion of the BAI for a high-priority population if the BAI is effective.